Identifying genes required for digestive physiology and lipid metabolism

Intestinal absorption of dietary nutrients is an important process contributing to the etiology of multiple
metabolic diseases that represent ~30% of worldwide mortality. An organism’s response to a high-fat meal
(HFM) requires coordination between multiple cell types in digestive tissues as well as the gut microbiota.
Enterocytes (EC) are the absorptive cells of the intestine that coordinate this response by temporarily storing
lipids in cytosolic lipid droplets (LD) and ultimately preparing them for circulation to distal tissues in ApoB-
containing lipoproteins (BLP). In parallel, enteroendocrine cells (EEC) sense and communicate nutrient
information to other cells and tissues via calcium-dependent hormone and neurotransmitter release. While the
roles of these cells in postprandial physiology are broadly acknowledged, the specific mechanisms mediating
EC and EEC postprandial responses to high-fat meal (HFM) and how microbiota influence those responses
remain unresolved. Our research team pioneered the zebrafish system for studies of lipid metabolism and
host-microbiota interaction. Over the past 10 years of this award, we have developed and applied highly
innovative tools in the zebrafish system to reveal new mechanisms of lipid metabolism, EEC physiology, and
host-microbiota interaction. The central hypothesis of this renewal is that a coordinated dynamic response to
HFM between EC and EEC is mediated by a suite of microbe-influenced transcription factors that ultimately
alter BLP and LD levels and turnover. Our research team has developed a set of novel tools to measure
digestive organ lipid uptake, transport, storage, and signaling. These include the first family of in vivo reporter
lines to quantify BLP size, numbers and turnover, as well as LD protein dynamics. In Aim 1, we will apply these
new tools along with genetic analyses to define the dynamics underlying LD and BLP responses to HFM and
microbes. We have previously used genetic approaches in zebrafish to identify host transcription factors
mediating responses to HFM and microbiota, and recently performed the first single cell nuclei RNAseq
analysis of an entire animal at a range of timepoints following a HFM. This approach allows us to interrogate
the transcriptional networks driving the postprandial response of digestive organs at unprecedented levels of
cellular and temporal granularity. In Aim 2, we will use these resources to define the transcriptional regulatory
pathways mediating intestinal epithelial response to HFM. We have also established tools for measuring EEC
responses to nutrients and microbes in zebrafish, and used them to reveal a novel microbiota-mediated EEC
postprandial adaptation after a HFM. In Aim 3, we will define the mechanisms underlying this microbiota-
induced EEC adaptation. This competitive renewal leverages long-standing partnerships between three field-
leading labs with a powerful set of mutant and novel transgenic reporter lines to elucidate the relationships
between EC, EEC, and microbiota. The zebrafish displays extensive homologies to that of humans and mice
and provides technical advantages not available in mammals that enable the proposed studies.

Public health relevance
NARRATIVE Alterations in fat metabolism contribute to the etiology of multiple metabolic diseases that ultimately accounts for over 30% of mortality worldwide. The proposed research is designed to discover key mechanisms by which intestinal epithelial cells and microbiota respond to a high fat diet, and is expected to lead to increased understanding and new treatments for human diabetes, cardiovascular, and other metabolic diseases. The proposed research is therefore relevant to the part of NIH’s mission that pertains to developing fundamental new knowledge that will enhance health and reduce the burdens of illness.